Point-of-need screening device for lung cancer in low-resource settings

PROJECT SUMMARY- Lung cancer is the leading cause of cancer death worldwide (estimated to be about 18%
of all cancer deaths), but an early diagnosis can substantially reduce mortality. In the US, an annual low-dose
computed tomography (LDCT) scan is the recommended screening method for those who are deemed as high-
risk due to age and smoking history. Merely 5.8% of eligible Americans were screened for lung cancer in 2021
and there exists a significant socioeconomic disparity in screening. Among underprivileged populations in
developing countries, lung cancer screening is practically non-existent due to resource constraints. The low rate
of lung cancer screening via LDCT is often attributed to the high frequency of false-positives and the lack of
LDCT infrastructure and trained operators in low-resource settings. Further, non-smokers are typically not
included in screening programs, although lung cancer rates have increased significantly in this group, particularly
in developing countries. There is a significant unmet need for a lung cancer screening tool that can be deployed
at the point-of-need to improve screening in vulnerable populations. To meet this need, Darwin Biosciences is
developing a low-cost, easy to use, handheld, and non-invasive lung cancer screening device that can be used
in low-resource settings in the US and worldwide, such as in community health centers, rural clinics, and in
healthcare facilities of developing countries. In ongoing work, under a $12 million contract with the DOD, Darwin
Biosciences has developed the first prototype of a handheld device that incorporates sample collection and
processing, isothermal recombinase polymerase amplification (RPA) of nucleic acid biomarkers, and a visual
readout of amplicons on lateral flow strips. This work was done for detecting pathogen-agnostic infection
biomarkers. In this Phase I project, this platform will be adapted for the detection of circulating tumor DNA
biomarkers which are validated in non-small cell lung cancer. The goal of this Phase I project is to develop and
optimize robust and sensitive assays for the detection of 3 biomarkers which are variants of EGFR (EGFR exon
19 deletion, EGFR Leu858Arg, EGFR Thr790Met) using saliva and capillary blood as biospecimens to enable
non-invasive testing. Aim 1: Primer selection for the 3 assays for EGFR-variant biomarkers: Primers for
RPA will be designed in silico and locked nucleic acids will be incorporated in the primers to enhance the
discrimination of single nucleotide variants. The designed primers will be bench tested to select one primer set
for each assay that shows minimal noise in the no-template control and strong signal in the template reaction.
Aim 2: Analytical characterization of the assays: The analytical performance of the 3 assays will be
determined in buffer and in biospecimens - saliva and capillary blood - by using samples with known amounts of
spiked templates. The target LOD will be a clinically relevant range of 10-100 copies/reaction and target
specificity will be <10% false positive with wild-type EGFR. Successful completion of this Phase I project is proof-
of-concept demonstration of detection of 3 lung cancer biomarkers in a portable, low-cost device.

Public health relevance
PROJECT NARRATIVE- Lung cancer is the leading cause of cancer death worldwide, estimated at 18% of all cancer deaths. Regular screening of high-risk populations leads to early diagnosis and can significantly decrease mortality; however, screening rates with the recommended method of low-dose computed tomography (LDCT) remain very low due to lack of access to LDCT among underprivileged populations and its high rate of false positives. In this project, Darwin Biosciences is developing a non-invasive, handheld screening device for detecting DNA biomarkers of lung cancer in saliva and capillary blood to enable improved lung cancer screening in low-resource settings.